Immunologic and Clinical Sequelae after COVID-19 in Patients with Systemic Autoimmune Rheumatic Diseases

PROJECT SUMMARY
The 5 million Americans living with systemic autoimmune rheumatic diseases (SARDs), such as rheumatoid arthritis (RA) and systemic lupus erythematosus (SLE), are at increased risk of poor COVID-19 outcomes. SARO treatment with immunomodulators may lead to blunted and dysregulated immune responses to vaccination and infection. SARDs are characterized by a predisposition to autoantibody formation and fibrosis. These factors may place SARDs at risk for poor short-term outcomes (e.g., breakthrough infection, prolonged viral shedding) and post-acute sequelae of COVID-19 (PASC), characterized by prolonged COVID-19 symptoms (>/=28 days). PASC is of high clinical and

Public health relevance
public health relevance in SARDs, affecting well over 20% of the general population. Further, the etiology and features of PASC in SARDs may be unique because of differences in their immune responses to infection and predisposition to autoimmunity and fibrosis. These studies will comprehensively investigate the immunologic and clinical outcomes after COVID-19 in patients with SARDs. To achieve our aims, we have assembled a cohort of vaccinated SARDs, systematically identified all SARDs with COVID-19, and are prospectively enrolling patients into an observational study. In the first aim, we will investigate risk for breakthrough infection after vaccination among RA patients on immunosuppressants. We will follow SARO patients acutely infected with COVID-19 to determine whether immunosuppressants prolong viral shedding that may result in viral evolution. In the second aim, we will measure autoantibodies as well as antibodies to pathogens to determine changes induced by COVID-19 and identify antibody profiles associated with PASC among SARDs. In the third aim, we will obtain chest imaging and respiratory phenotyping to determine if COVID-19 may induce fibrotic lung disease in RA patients. Dr. Jeffrey Sparks (Assistant Professor of Medicine at Brigham and Women's Hospital and Harvard Medical School, HMS) and Dr. Zachary Wallace (Assistant Professor of Medicine at Massachusetts General Hospital, HMS) will lead these studies as Principal Investigators. Dr. Sparks and Dr. Wallace are rheumatologists and research leaders related to SARDs and the COVID-19 pandemic. The PIs have assembled a cohort of all SARO patients with confirmed COVID-19 in the Mass General Brigham system, composed of 2 large tertiary care centers and 12 community hospitals. They are prospectively enrolling these patients after COVID-19 to study PASC. These studies have high potential for impactful results related to risk of breakthrough infection and formation of variants, determining humoral immune correlates of PASC, and determining how respiratory viral diseases may impact SARDs patients.